Dysregulation of the Human Ubiquitin Proteasome System in Pediatric Severe Malarial Anemia

PROJECT SUMMARY
The proposed study is a four-year mentored research career development program aimed at understanding
dysregulation of the Human Ubiquitin Proteasome System (UPS) in children (age, ≤ 48 months) presenting with
severe malaria anemia (SMA; Hb<5.0g/dL) at a rural County referral hospital in western Kenya, a holoendemic
region for Plasmodium falciparum malaria. The Principal investigator, Samuel Bonuke Anyona, PhD is currently
a Lecturer of Medical Biochemistry at the School of Medicine, Maseno University, Kenya. The proposal
presented builds on recent research and adds new learning domains of advanced training in the generation of
transcriptomic data, analysis of complex transcriptomic and biochemical pathways, and therapeutic/drug
discovery. These tasks will be achieved through research investigations that will be conducted in Dr. Douglas J.
Perkins (Primary Mentor) laboratories at the University of New Mexico, USA, and the Maseno-UNM facilities in
Kisumu and Siaya, Kenya. The proposed experiments will transition the investigator towards independence as
a scientist in infectious diseases, with a focus on the UPS. In addition, the K43 program will equip the investigator
with new skill sets and foster collaboration with world-class scientists. Malaria remains a significant global health
burden, with an estimated 219 million (95% confidence interval [CI]: 203–262 million) cases reported worldwide
in 2017. In western Kenya, P. falciparum malaria remains one of the leading causes of childhood morbidity and
mortality with the primary severe disease manifestation being SMA. The Ubiquitin-Proteasome System (UPS) is
a major pathway for intracellular protein degradation and regulation of basic cellular processes. Both
proteasomes and ubiquitin are associated with various clinical syndromes. During host-pathogen interactions,
the UPS is important for antigen processing, and falciparum parasites have the ability to modify the host
proteome for improved survival in infected erythrocytes. However, the impact of malaria on the host UPS remains
unreported. Our recent investigations on human ubiquitylation gene expression profiles showed that children
with SMA have dysregulation in the UPS. To build on these preliminary investigations, and to further decipher
the role of the human UPS in the development of SMA in children, the proposed study aims to: 1) Identify genes
in the host UPS that contribute to the development of SMA, 2) Determine if children with SMA have altered
protein homeostasis (cellular stress) due to perturbations in the UPS, and 3) Identify compounds that modify the
human UPS that could serve as future therapeutics for the treatment of malaria.

Public health relevance
PROJECT NARRATIVE Children living in high transmission regions for Plasmodium falciparum, the most deadly malaria parasite, suffer from ?61% of the malaria deaths, of which 93% occur in Africa. The main cause of severe disease and death in these children is from profoundly low hemoglobin (Hb<5.0g/dL) levels, classified as severe malarial anemia (SMA). We aim to study the human Ubiquitin Proteasome System (UPS) which is an important pathway for host-pathogen interactions, yet remains unexplored in human malaria, including in Kenyan children who will be the focus of our studies.